PFAS Exposure and Diabetic Kidney Disease in Youth with Type 2 Diabetes: A Multi-Omic Approach for Prevention and Treatment

PROJECT SUMMARY / ABSTRACT
Over 50% of youths with type 2 diabetes (Y-T2D) develop diabetic kidney disease (DKD) during adolescence,
increasing the risk of early dialysis and death. Latinx and African American youth are disproportionately affected
but under-studied, and current treatment options for T2D in adolescents, projected to dramatically increase over
the coming decades, are limited. Thus, it is critically important to identify modifiable risk factors and novel
therapeutic approaches for preventing DKD in youth. Our strong preliminary data links per- and polyfluoroalkyl
substances (PFAS), a group of ubiquitous artificial chemicals used for more than 60 years in consumer and
industrial products, with kidney injury in proximal tubules in Y-T2D, a key component of DKD. PFAS toxicity in
proximal tubules may be partly due to organic anion transporters (OATs) localized to these cells; Tubular OATs
reabsorb PFAS from urine filtrate, concentrate PFAS in tubular cells, and decrease renal PFAS clearance,
potentially amplifying PFAS associated nephrotoxicity. Our overarching biological hypothesis, supported by our
preliminary data, is that PFAS increases tubular injury and DKD risk and that decreasing OAT reabsorption in
proximal tubules may mitigate this risk. This first of its kind study will examine this hypothesis by building on
existing data in two independent, meticulously phenotyped, longitudinal cohorts of youth with T2D of
predominantly Latinx or African American race/ethnicity. To identify associations and potential therapeutic
targets, we will leverage the NIDDK-funded Renal Hemodynamics, Energetics, and Insulin Resistance in Youth
Onset Type 2 Diabetes Study (Renal-HEIR/HEIRitage). This study has existing measures of OAT activity
measured using single cell RNA sequencing from kidney biopsies at baseline and gold-standard PAH clearance,
a measure of tubular OAT function, in addition to existing outcome data, including tubular injury biomarkers,
albuminuria, and hyperfiltration at both visits. To examine associations in a larger cohort with annual visits and
longer follow-up duration, we will leverage the NIH/NIDDK funded TODAY/TODAY2 study, the largest
longitudinal cohort of youth with T2D with comprehensive measures of kidney function (e.g., annual visits for 15
years) with the same outcomes as Renal-HEIR. In both cohorts, we will assess PFAS exposure and clearance
by measuring longitudinal serum PFAS and urine PFAS at baseline; we will assess biomarkers of OAT function
in urine and plasma and address reverse causality using pharmacokinetic (PK) models. We will use innovative
statistical approaches, including a latent unknown factor analysis to identify how OAT activity associates with
changes in PFAS over time, and a novel causal inference and mediation framework based on latent factors to
examine whether decreases in OAT activity, induced by sodium/glucose cotransporter-2 inhibitors, decrease the
risk of DKD via alterations in renal PFAS clearance. This groundbreaking study will deepen our understanding
of the interplay between OATs, PFAS, and DKD in youth with T2D and inform targeted clinical interventions to
prevent PFAS associated DKD, particularly in marginalized communities.

Public health relevance
PROJECT NARRATIVE Diabetic kidney disease (DKD) in youth with type 2 diabetes (T2D) dramatically increases the risk of early kidney failure and mortality and is increasing in prevalence, but preventive therapies are limited. Exposure to per- and polyfluoroalkyl substances (PFAS) may increase DKD risk in youth with T2D and is associated with altered renal organic anion transporters, which actively reabsorb PFAS from urine, concentrate PFAS in proximal tubules, and potentially increasing PFAS nephrotoxicity and risk of DKD. In this first-of-its-kind study, we will leverage two longitudinal cohorts of youth with T2D to examine how organic anion transporters and exposure to PFAS affect DKD risk in youth and identify potential therapeutic targets and prevention approaches for mitigating PFAS associated nephrotoxicity in high-risk populations.